MATERNITY CARE: SCIENCE, GUIDELINES, MEDICAL PRACTICE

The purposes of the conference are to review scientific findings/a meta analysis of clinical trials on maternity care and childbirth; to discuss alternative methods of developing practice guidelines; change practice behavior; and discuss the public policy implications of such studies and guidelines development. Finally, the papers and proceedings of the conference will be widely disseminated. (1) Scientific findings. The Enkin, Chalmers, Keirse meta analyses of effective care in pregnancy and childbirth will be summarized. Commentaries will be presented on the scientific methodology, from the clinical perspective and the translation of scientific findings to policy. (2) Guidelines. Alternative methods of assessment as the basis for the development of guidelines will be described and analyzed. These include: The Rand approach, the NIH consensus approach; the AHCPR Forum approach and the outcomes approach. (3) Changing Practice Behavior. Implications for medical education; influencing provider behavior; patient education are the topics with a discussion from an international perspective and a commentary from a federal government perspective. (4) Policy Implications. The discussion will include implications for reimbursement policy, state policy, regulatory policy. (5) Dissemination. The conference papers will be published in International Journal of Technology Assessment in Health Care and/or the Milbank Quarterly. Proceedings will be prepared and disturbed. A press conference will be scheduled for the end of the conference.